Optimizing the Validity of the Multidimensional Assessment of Interoceptive Awareness to Predict Disordered Eating

The overarching goal of this R16 SuRE project is to optimize the validity of the Multidimensional Assessment of Interoceptive Awareness (MAIA) for evaluating mind-body interventions. Interoception is defined as one's ability to adaptively interpret and respond to signals from within the body. Many interoceptive responses are autonomically driven; others are within the realm of subjective experience. The subjective facet is termed `interoceptive sensibility' which is measured using self-report questionnaires—of which the MAIA is the most comprehensive and broadly adopted. Interoceptive sensibility has wide-ranging implications on human health. Deficits in interoceptive sensibility are a well-established transdiagnostic feature of eating disorders and psychopathology in general. Better understanding this trait has implications for phenotyping eating disorders and other mental health conditions. Targeting interoceptive sensibility in mind-body interventions is a growing area of research. However, operationalizing this construct has been limited by measurement inconsistencies and problems with validity. We recently conducted preliminary psychometrics and validity testing of the MAIA's underlying common factor model (N=1294) and supported the original eight-dimension factor structure. Our preliminary data also suggested measurement non-invariance across demographic groups and potential unobserved population heterogeneity, which limit our ability to use the tool to evaluate interventions, as intended. This proposal aims to address these concerns. We will collect survey data from a US Census- matched sample of adults (N~2000) using an online platform. Our first aim will apply moderated nonlinear factor analysis (MNLFA) to create person-specific factor scores that optimize the validity of using the MAIA to make group comparisons, predict distal outcomes, and measure change. The MNLFA procedure identifies which questions on the MAIA have differential item functioning across a group of relevant background and psychosocial characteristics, including biological sex, age, body mass index, disordered eating, negative body image, and traumatic stress. MNLFA adjusts the scoring algorithms for the factors of the scale to account for population heterogeneity. Our second aim will apply latent profile analysis (LPA) to identify a typology of interoceptive sensibility by clustering unobserved groups of people who tend to score similarly on the multiple dimensions of the scale. LPA applies a person-centered approach instead of the more dominant variable- centered approaches (such as confirmatory factor analysis) as an alternative dimension reduction technique. The resulting typology will serve as prototypes of interoceptive sensibility with which we will generate and test hypotheses about how the components of the MAIA interact to predict disordered eating and the associated risk factors of negative body image and traumatic stress. In summary, one of the most impactful long-term contributions of this project is to increase the rigor of the MAIA measurement model to expand the field's capacity to evaluate the next generation of targeted, accessible, and broadly effective mind-body interventions.

Public health relevance
Interoceptive skills serve a critical function to human health and well-being. Using novel quantitative approaches, this research will advance public health knowledge by addressing the current limitations in the measurement of interoception to strengthen the validity of a widely adopted tool for examining interoceptive sensibility in the context of mind-body interventions. The project will also contribute new information about how the dimensions of interoceptive sensibility interact to create a typology of interoceptive skills and deficits that can ultimately be used to predict distal health outcomes.